Microfluidic cell squeezing platform for the transdifferentiation of somatic cells for efficient generation of a cell replacement therapy for Parkinsons Disease

PROJECT SUMMARY:
Major diseases, such as heart failure, Parkinson’s Disease (PD), type 1 diabetes, and age-related macular de-
generation, are examples of organ and systemic failure driven by damage to specific cell types. One possible
therapeutic solution is to replace the damaged cells with ex vivo engineered, physiologically functional cells to
alleviate clinical symptoms. However, expensive, time-intensive, and inefficient cell reprogramming methods for
generating transplantable therapeutic cells for degenerative disorders hinders development and clinical transla-
tion of potentially transformative therapies. Our goal is to develop a highly efficient process for producing cell
replacement therapies that can be reliably manufactured at-scale to treat currently intractable diseases such as
Parkinson’s Disease. This goal will build upon our patented and proven Cell Squeeze® technology that can
deliver materials including mRNA, proteins, and peptides into sensitive primary cells. For this Phase II SBIR
proposal, our overall objective is to demonstrate that with Cell Squeeze® technology we can introduce transcrip-
tion factors that can increase the efficiency of transdifferentiating peripheral blood cells (PBMCs) into clinically
relevant dopaminergic neurons. Our central hypothesis is that we can precisely control the timing, dose, and
combinations of transcription factors to create high quality, functional cell products in greater quantities in a
shorter time than is possible with current methods and free of risks associated with viral gene delivery. Support-
ing this goal, we have already demonstrated that the squeeze treatment alone does not significantly affect gene
expression, we can efficiently generate neurons from iPSCs, and we can introduce multiple transcription factors
into PBMCs to upregulate expression of key neuronal signaling pathways. The rationale is that our non-viral
method of delivering transcription factors to drive cell fate could significantly improve the efficiency and efficacy
of cells produced with fewer safety and regulatory concerns as compared to other methods of transdifferentiation.
Furthermore, in comparison to allogeneic iPSC derived products, autologous cells would not require chronic
immunosuppression – a key factor to ensure long term health of the patient. In Aim 1, we seek to optimize
methods for the Cell Squeeze® technology to deliver mRNA-based transcription factors to PBMCs to drive effi-
cient transdifferentiation into dopaminergic neurons (DNs). Resultant DNs will be thoroughly characterized in
vitro and compared to DN generated from iPSC using existing methods. In Aim 2, these DNs will be functionally
assessed in an in vivo murine PD model to support the further development into a potentially transformative cell
therapy. Successful completion of these aims may support partnering opportunities with other biopharmaceutical
companies who are seeking differentiated cell therapy approaches in neurodegeneration.

Public health relevance
PROJECT NARRATIVE: Cell therapies that replace lost or damaged cells in diseases such as Parkinson’s disease, type 1 diabetes, macular degeneration, and others, have shown the potential to improve patient outcome. However, current meth- ods for generating these cell therapies are difficult to translate into the clinic because of limited production effi- ciency and safety concerns related to the production methods. This research would support the development of Cell Squeeze® technology, a non-viral delivery system, for efficient cell reprogramming to potentially improve the quality of cell replacement therapies.